Wake Forest Claude D. Pepper OAIC - Renewal

Funded since 1992, the Wake Forest Older Americans Independence Center (WF OAIC) has
developed and tested interventions to improve physical function and prevent disability by
applying a translational approach that integrates medicine, behavioral and cognitive science,
biostatistics, muscle and adipose tissue biology, pertinent animal models, genomics, novel
imaging modalities, and clinical and population approaches.
Based on its theme, integrating pathways affecting physical function for new approaches
to disability treatment and prevention, the WF OAIC will pursue four programmatic aims:
1. Discover new pathways contributing to age-related declines in physical function and
disability risk;
2. Develop, evaluate and refine strategies for disability treatment and prevention;
3. Translate proven strategies beyond the traditional research environment; and
4. Train the next generation of research leaders focused on disability treatment and
prevention.
This renewal builds on the substantial achievements of the 2018-2023 cycle in which the WF
OAIC made significant scientific progress supporting 62 externally-funded projects, 12 early-
career faculty, and developing new mHealth and image processing tools. The WF OAIC will
advance its aims in the first year of the next cycle by supporting four pilot studies, two research
development projects, four early-career faculty and 23 externally-funded projects.
The aims will be pursued by integrating the efforts of four highly productive research support
cores: the Clinical Research Core; Integrative Biology Core; Biostatistics and Research
Information Systems Core; and Bioimaging Resource Core. Under the continuing and
dedicated leadership of Drs. Stephen Kritchevsky and Dalane Kitzman, the Leadership and
Administrative Core will coordinate these research core activities with those of the Research
Education Component and the Pilot and Exploratory Studies Core.

Public health relevance
In anticipation of the needs of the growing number of older adults, the WF OAIC will identify and evaluate novel strategies to prevent physical disability and return disabled older adults to independence using its highly integrated translational research and training infrastructure.